Nitric oxide reactions in metalloenzymes

DESCRIPTION (provided by applicant): The long-term goal of this research is to elucidate the reaction mechanisms of NO reduction that occur at heme and non-heme diiron centers of bacterial metalloenzymes. Our studies will focus on two enzymatic systems and related bioengineered or synthetic models: 1) NO-detoxifying flavodiiron proteins (FDPs) and 2) denitrifying NO reductases (denNORs). All of the proteins within these two families are known to reduce NO to the unreactive N2O product, but they do so with wide variation in efficiency and protein matrix structure. Although several of these proteins have been characterized by X-ray crystallography, the initial steps of NO binding, iron-nitrosyl reduction, and how these catalytic events differ between systems are not well understood. The coupling of resonance Raman, FTIR, and EPR spectroscopies with rapid-freeze-quench analyses provides unique capabilities to define NO-binding geometries at diiron clusters and to follow the N-N bond formation, N-O bond cleavage, and protonation steps that must take place to convert two NO molecules to N2O and H2O. Studying a diverse group of native enzymes and models will allow us to compare and contrast structural information on iron-nitrosyl intermediates and the efficiency of the reductive and proton transfer steps of this reaction. Public health relevance: A better understanding of microbial NO reductases is highly desirable since these enzymatic reactions lead to microorganisms' resistance to the mammalian immune response. Furthermore, there are no human orthologs to these microbial enzymes; they represent potential targets for new drugs. PUBLIC HEALTH RELEVANCE: The goal of this research is to elucidate the mechanisms of NO detoxification employed by microorganisms to combat the mammalian immune response. While many metalloenzymes involved in this process are structurally distinct from one another, they have in common an active site containing two iron ions. To understand the reaction of these diiron sites with NO will require a combination of rapid kinetic analyses and complementary molecular spectroscopies.

Public health relevance
The goal of this research is to elucidate the mechanisms of NO detoxification employed by microorganisms to combat the mammalian immune response. While many metalloenzymes involved in this process are structurally distinct from one another, they have in common an active site containing two iron ions. To understand the reaction of these diiron sites with NO will require a combination of rapid kinetic analyses and complementary molecular spectroscopies.